CORE--CYTOGENETICS

With the recognition that cancer is a genetic disease, many cancer researchers, including scientists in the Mayo Clinic Cancer Center (MCCC), require access to routine and advanced cytogenetics services. Such services can aid in the identification of genetic regions important for the development of specific malignancies. Such services can also be used to characterize the clonality of tumor specimens and determine the origin (e.g., mouse vs. human) of a specific tumor culture. Thus, the Cytogenetics Shared Resource will provide cytogenetic and molecular cytogenetic services to MCCC members. In addition, this Shared Resource will prepare EBV-transformed B-lymphocyte cell lines for MCCC members.